Core B: Genetically Engineered Mouse Core

Project Summary/Abstract (Core B, Barton) Core B of this Program Project Grant (P01) will maintain a colony of mouse strains with deficiencies in components of innate immunity or other genetic modifications useful for the study of innate immunity and the host response to pathogens. Core B also supports the generation of new mouse strains using Cas9-mediated genome editing. This new technology enables rapid and affordable generation of knock-out and knock-in mice. Core B will work with each of the Project Labs to develop new mouse strains that will facilitate hypothesis testing. Mice are cells from the mice maintained within Core B will be distributed to each of the projects within the P01. All mouse strains have been or will be backcrossed onto the C57BL/6J genetic background to equivalent degrees. Core B will reduce overall mouse costs due to economies of scale. In addition, each P01 project will benefit from using cells and mice with fewer genetic and experimental variations.

Public health relevance
Project Narrative (Core B, Barton) Core B will provide mice and cells lacking key immune genes to each of the projects within this P01 application. Experiments using these materials will dissect how the immune system detects and responds to a broad range of pathogens.